IMAT-ITCR Collaboration: Hyperplex lineage analysis of tumor heterogeneity and interactions with the microenvironment

ABSTRACT
Tumor cell heterogeneity and dynamic changes to tumor cell states are major contributors to tumor
initiation, growth, metastasis, and treatment resistance. The Snyder lab and the Yanai lab are each
developing their own technologies in separate NCI funded studies for respectively visualizing tumor
heterogeneity in mouse models with hyperspectral lineage tracing (NCI IMAT, Snyder, MousePaint) or
reconstructing spatial relationships and cancer cell states using single cell genomics technology (NCI
ITCR, Yanai, SNAP). Our hypothesis is that application of the MousePaint and SNAP technologies on
the same dataset will benchmark these technologies for (1) viewing thousands of colors (i.e. clones) in
vivo and for (2) inferring tumor neighborhoods from scRNAseq data. Two aims are proposed. Aim 1. To
generate MousePaint cell lines for assessing color diversity and clonal neighborhoods using
hyperspectral imaging. Aim 2. Benchmarking SNAP and MousePaint by coregistering single cell
genomics data with MousePaint imaging data. The collaborative supplement will have substantial
positive impact on each parent award by providing new models and algorithms for benchmarking Dr.
Snyder’s hyperplex lineage tracing strategies as well as providing experimental models for Dr. Yanai’s
SNAP single cell genomics approaches. We expect these studies to 1) validate resources for the research
community to study tumor heterogeneity and 2) provide new insight into the early changes that occur in
the tumor microenvironment during cancer initiation and growth.

Public health relevance
PROJECT NARRATIVE The proposed supplement project will enable a pilot collaborative research study between an NCI IMAT funded laboratory (Dr. Snyder, Duke University) and an NCI ITCR funded laboratory (Dr. Yanai, NYU Grossman School of Medicine). In this supplement, IMAT and ITCR technologies will be used together to benchmark novel tools for the spatial analysis of tumor heterogeneity.